AI-based platform for predicting emerging vaccine-escape variants and designing mutation-proof antibodies

Project Summary
Due to massive vaccination, coronavirus disease 2019 (COVID-19) pandemic caused by the
severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) has been partially under control.
However, emerging contagious variants such as Delta are still fueling new waves of infections
around the world. Vaccine-escape (or vaccine-breakthrough) variants pose renewed threats to
our battle against COVID-19. Understanding viral mutagenesis and evolution is of preeminent
importance. By integrating genomic analysis, artificial intelligence (AI), computational biophysics,
advanced mathematics, and experimental data, the PIs have built a comprehensive program with
the experimental level of accuracy and population-level of reliability for predicting SARS-CoV-2
variant infectivity and antibody disruption. It remains challenging to forecast future emerging
vaccine-escape variants, to develop the next-generation of vaccines, and to design mutation-
proof antibody therapeutics. These challenges are tackled in the proposed project. New
mathematical tools and AI algorithms will be developed to further improve the current state-of-
the-art in predicting mutation-induced viral infectivity changes, vaccine breakthroughs, and
antibody disruptions. Vital mutations in future emerging variants will be forecasted based on
molecular mechanisms, natural selection, and evolutionary effects. New mutation-proof antibody
drugs will be designed and tested based on those antibodies that had gone through earlier clinical
trials. The predictive models will be implemented into a user-friendly platform with online servers
for researchers to design mutation-proof new vaccines and antibody therapies. The proposed
methods will be applied to forecast emerging variants in the flu and improve the efficacy of
seasonal flu vaccines.

Public health relevance
Project Narrative The project concerns the development of genomics, artificial intelligence, biophysics, mathematics, and experiment-based platform for the prediction of vaccine-escape mutations and design of mutation-proof antibodies. This development is of life-saving importance.